Reexamining the Role of Dendrites in Neuronal Function

The textbook model of a neuron is one where dendrites merely serve as recipients of
excitatory or inhibitory synaptic inputs, integrated at the soma to generate action
potentials. However, dendrites generate local spikes that could be critical nonlinear
decision points, and recent data suggest that excitatory inputs may only have an effect in
the neuronal output if they are activated together in clusters, triggering dendritic spikes.
We want to re-examine the role of dendrites in neuronal function in vivo and help usher
in, a new “dendrocentric” paradigm of how neurons work, as opposed to the current
“somacentric” one. To bring this change, we will assemble a “Dendrite Consortium” of
complementary laboratories, expert in genetically-encoded voltage indicators, volumetric
two-photon imaging, holographic optogenetics and optochemistry, dendritic patching,
EM connectomics, superresolution synaptic mapping and computational models. Wwe
will use holographic optogenetics to activate dendritic spines in arbitrary patters (as if
one were “playing the piano”), while imaging voltage in 3D with new GEVIs in dendrites
from a subtype of L2/3 pyramidal neuron from mouse visual cortex in vivo during
sensory stimulation and spontaneous activity, combining this with direct patch recordings
from dendrites. These experiments will characterize the functional regimes that generate
dendritic spikes in vivo and elucidate their biophysical mechanisms and overall impact
on somatic spiking. We will then use connectomics and expansion microscopy to
reconstruct complete morphologies and synapse compositions of these dendrites,
including imaged ones. These combined functional and structural data will be used to
build a rigorous computational model of the neurons, where the functional and
computational roles of dendritic spikes will be explored numerically and systematically.
Through a collective, integrated effort, we will elucidate the computational logic and
functional roles of dendrites and help usher in a new working model of a neuron. We will
also generate for the field open-access morphological, functional and computational
datasets of complete dendritic trees from one pyramidal neuron subtype, activated by
sensory stimulation or intracortical activity. These datasets, including “Rosetta” ones of
the same exact neuron, could enable answers to outstanding basic questions on
dendritic function in normal and pathological states, as dendrites are central functional
elements in all brain circuits and are affected in many neurological and mental disorders.

Public health relevance
The traditional paradigm of how neurons work assumes that dendrites receive excitatory and inhibitory synaptic inputs that are integrated in the soma, but dendrites are active nonlinear structures that could mediate, and control, which of the many thousands of inputs are integrated and which are not. We will assemble an interdisciplinary consortium of laboratories and use state-of-the-art experimental and computational methods to examine with unprecedented detail the structure, in vivo function and computational roles of dendrites of a mouse pyramidal neuron subtype in visual cortex. This work will elucidate the principles underlying the function of dendrites in pyramidal neurons and generate a series of complete morphological, connectivity, functional and computational datasets that could be used as “Rosetta Stones” by the field for futures studies of neurons in both normal and pathological states.